Neural mechanisms of interpretation shifting and memory formation in ambiguous social contexts

PROJECT SUMMARY
In our daily lives, we frequently encounter ambiguous information. Navigating this ambiguity—generating
interpretations, adapting them in response to new information, and encoding them in memory—plays a pivotal
role in shaping our thoughts and behaviors. Biases in interpretation and memory are both risk factors and
symptoms for major depressive and anxiety disorders, with clinical strategies like cognitive reappraisal—
deliberate, targeted changes in how someone interprets a situation—aiming to mitigate these biases. However,
past work has either focused on isolated parts of this process (e.g., how someone forms an interpretation without
examining their likelihood of shifting it) or used simple perceptual stimuli (e.g., visual illusions) where individuals
alternate between a small number of definitive percepts. Real-world scenarios, particularly social ones, are
inherently more subjective and thus, are more likely to reveal biases associated with conditions like depression
or anxiety. Despite their importance, social scenarios have received limited attention in this research context,
possibly because of the difficulty in balancing experimental control with ecological realism. This proposal aims
to address these gaps by combining functional magnetic resonance imaging (fMRI) with a novel behavioral task
paradigm that mimics real-life social ambiguities. Leveraging advancements in natural language processing
(NLP), my task involves presenting participants with ambiguous social scenarios, collecting their subjective
interpretations, and then exposing them to alternative views from other participants. NLP enables the objective
comparison of a virtually unlimited number of interpretations in order to generate alternatives in real time that
are tailored to how the participant just interpreted an image. Past work has demonstrated that multivariate neural
patterns reflect differences in percepts and interpretations across subjects as well as changes in percepts within
subjects, even when sensory input is held constant. My study will investigate where and how shifts in neural
patterns to the same sensory information (namely, ambiguous social photographs) predict changes in
interpretations (Aim 1) and the encoding of these interpretations into memory (Aim 2). I anticipate that I will find
distinct, yet complementary, neural substrates supporting these behaviors. Ultimately, this research will yield a
mechanistic model explaining where, how, and why the same sensory information can lead to different subjective
interpretations and how these interpretations are encoded into memory. This model will contribute to our
fundamental understanding of these cognitive processes and will also generate testable hypotheses for
therapeutic interventions aimed at normalizing interpretational and memory biases related to subjective
information.

Public health relevance
PROJECT NARRATIVE The ability to resolve ambiguous information is vital in our daily lives. Disrupted interpretive processes and memory biases for ambiguous information are core risk factors and symptoms for major depressive and anxiety disorders. The proposed research will investigate the neural mechanisms that underlie how—when faced with ambiguous social scenarios—individuals initially form, update and ultimately remember subjective interpretations.